Consequences of fentanyl self-administration during pregnancy

ABSTRACT
Opioid abuse of pregnant women or women of childbearing age in general is an urgent public health concern.
The number of women using opioids presenting at labor and delivery has more than quadrupled in the last
decade. While the imminent effects of opioid use during pregnancy, namely neonatal opiate withdrawal
syndrome, are well described, there is only limited knowledge about the long-term harmful effect of opioid abuse
during pregnancy on the developing child. This proposal aims to investigate the effects of prenatal fentanyl
exposure, and its short- and long-term consequences on the offspring – from infancy through adulthood- using
a translationally relevant approach in which rat dams self-administer fentanyl intravenously under extended-
access conditions prior and throughout pregnancy. In one specific Aim we will test the hypothesis that daily
extended-access to intravenous fentanyl self-administration constitutes a translationally relevant model of
fentanyl abuse on pregnant women, that induces neonatal opioid withdrawal, impaired offspring development,
and altered sensitivity to opiates that persists throughout adulthood.
We will assess comprehensively the overall health, occurrence and severity of neonatal opiate withdrawal and
achievement of age-appropriate somatic and behavioral developmental milestones by the offspring, followed by
evaluation of sensitivity to opiates. In comparison to pups from yoked saline control dams, we expect that
prenatal fentanyl exposure will lead to delayed achievement of developmental milestones, and increased
sensitivity to fentanyl, and we expect the severity of deficits will be directly related to level of fentanyl exposure.
In addition, we expect that improved maternal care, as achieved by cross-fostering of litters between fentanyl
and saline dams, will ameliorate the observed developmental effects. The results from the proposed studies will
provide needed information regarding the role of fentanyl exposure itself, the presence/severity of opioid
withdrawal and altered maternal care in the persistent physical and behavioral impairment of pups exposed to
fentanyl. Ultimately, our studies should lead to knowledge that is vital for the identification of treatment
opportunities, both pre- and postpartum.

Public health relevance
NARRATIVE Opioid abuse in women of childbearing age or who are pregnant is a major public health threat. The number of women abusing opioids presenting at labor and delivery has more than quadrupled in recent years, with fentanyl abuse rising to an all-time high, putting the fetus at serious risk for opioid withdrawal, as well as developmental and behavioral impairments. The experiments proposed in this application aims to investigate the effects of prenatal fentanyl exposure and its short- and long-term consequences on the offspring and these results will serve public health interests by providing knowledge which may lead to the development of effective interventions to improve the well-being of drug abusing pregnant women and protect their highly vulnerable offspring.